CHEMISTRY, MANUFACTURING, AND CONTROLS (CMC) DEVELOPMENT OF NCGC00413972 FOR PRECLINICAL SAFETY EVALUATION AND CLINICAL TRIAL

The overall objective of this project is for the contractor to support the chemistry, manufacturing, and controls (CMC) development of NCGC00413972 for preclinical safety evaluation and clinical trial.